Dissecting the mechanism of increased genomic instability in aging yeast

PROJECT SUMMARY Age is the greatest carcinogen, yet the mechanism by which the incidence of cancer dramatically increases as humans age is unclear. In an effort to better understand this phenomenon, we developed a system in the yeast Saccharomyces cerevisiae that recapitulates one of the hallmarks of cancer - genomic instability - as a function of cellular age. Specifically, we examined the relationship between aging and genomic instability by monitoring loss of heterozygosity (LOH) on different chromosomes during replicative aging in yeast. We discovered that aging yeast mother cells underwent a switch to a nearly 100-fold increase in LOH in their progeny. Recently, we gained a better understanding of this phenomenon and have developed a working hypothesis that breaks the age-associated LOH into a series of connected events. It begins with a loss of, or damage to, the mtDNA. This leads to a reduction in the inner mitochondrial membrane potential ( ¿), which in turn leads to a defect in iron-sulfur cluster (ISC) biosynthesis and/or assembly of the ISCs into proteins required for maintenance of genome integrity. The reduced function of these genome integrity proteins then leads to increased levels of LOH. This hypothesis serves as a working model to formulate our questions and approaches. We now propose to test the steps in this hypothesis using the powerful collection of resources and tools available in S. cerevisiae. As part of this approach, we developed an inducible genetic system, the Mother Enrichment Program (MEP), which permits for the first time the facile isolation of replicatively aged S. cerevisiae cells for biochemical, cell biological and genetic analysis. This will permit us to gain further understanding of the earliest events in aging that ultimately lead to age-associated LOH. Because each of the processes in this progression to age-associated LOH are conserved, we believe that what we learn in the proposed plan will ultimately be translatable to identifying candidate genes and processes in humans that are similarly affected by aging and lead to age-related oncogenesis.

Public health relevance
Project Narrative There is a striking link between increasing age and the incidence of cancer in humans. Though the simple organism baker's yeast does not get cancer, we have found that older yeast cells exhibit a dramatic increase in one of the hallmarks of cancer: genomic instability. In this proposal we will use yeast as a model system to identify and understand the factors responsible for this instability in order to gain insight into how age impacts the incidence of oncogenesis. __SpecificAimsTextDelimiter__ Dissecting the mechanism of increased genomic instability in aging yeast SPECIFIC AIMS There is a clear correlation between incidence of cancer and advancing age in much of the human population. While there are many hypotheses to explain the cause of cancer, genome instability certainly plays a role. There is good evidence that with increasing age, normal genome integrity deteriorates; this in turn facilitates oncogenesis. In order to explore what causal links exist between aging and cancer, we are using replicatively aged yeast (S. cerevisiae) as a model system for dissecting the mechanism underlying increased genomic instability with advancing cellular age. To this end, we analyzed genome integrity in S. cerevisiae cells as they aged and discovered that genomic instability does indeed increase with advancing age in yeast cells. The genomic instability is manifested as a dramatic increase in loss of heterozygosity (LOH) in the progeny of older cells. Interestingly, once an initial LOH event occurs in a progenitor cell, the cell remains in a hyper-LOH state as all subsequent progeny cells have a higher frequency of genomic instability. In the past funding period, we have moved our understanding of age-associated LOH in yeast from a simple phenomenon to a testable model that can now be dissected experimentally. We hypothesize that age- associated LOH can be explained by a cascade of molecular events that begins with a loss of mitochondrial DNA (mtDNA) that occurs as a function of replicative age. The resulting mitochondrial dysfunction leads to a reduction in iron-sulfur cluster (ISC) biogenesis. This in turn leads to reduced activity of ISC-requiring proteins, including those involved in maintenance of nuclear genome integrity. We also recently developed an inducible genetic system, the Mother Enrichment Program (MEP), which allows for the first time the facile isolation of replicatively aged S. cerevisiae cells for biochemical, cell biological and genetic analysis. This technology permits us to examine and dissect age-associated phenotypes that could not be studied before in yeast, or any other system. We plan to combine this new technology with our recent insights about age-associated LOH to develop a molecular understanding of this age-related phenomenon. Specifically, we will address the following questions: 1. What age-associated events lead to loss/damage of mitochondrial DNA? Here, we will build the foundation for understanding the link between cellular aging and age-associated LOH. We will take advantage of our newly developed MEP to characterize the fate of the mitochondrial genome during the aging process. As part of this analysis we will carry out a genetic screen for suppressors of the age- associated mtDNA loss. The genes identified in this screen will allow us to uncover specific pathways and mechanisms that are critical to mtDNA maintenance/transmission, but that become defective with age. 2. What aspects of iron-sulfur cluster biosynthesis are compromised when mitochondrial DNA is lost? Fundamental to our overall hypothesis is that iron-sulfur cluster biogenesis is compromised after mtDNA is lost. Here we will focus on the steps of ISC biosynthesis that normally occur in the mitochondria and determine which factors/proteins are compromised after mtDNA is lost. This information will serve as a resource for the experiments in Specific Aim 3, as well as allow us to develop a mechanistic understanding of the constraints imposed on ISC production when mtDNA is lost or damaged. 3. How does reduced ISC biogenesis lead to nuclear genome instability? This question addresses the last step of our hypothesized cascade of events that lead to age-associated LOH. Using genetic screens with biochemical analyses of candidates, we will identify the gene product(s) important for nuclear genome integrity that become compromised upon ISC reduction. Characterization of these gene product(s) will provide us with the information we need to fully understand how upstream events in the mitochondria ultimately result in a defect that causes age-associated LOH. To understand the progression to age-associated LOH in S. cerevisiae, each of the Specific Aims we propose examines a conserved cellular process/structure. This work will also make considerable contributions to basic chromosome and mitochondrial biology. As a result, what we learn at each step of the proposed plan has the potential to impact future considerations about human health and underappreciated consequences of aging.